Hormones & Behavior Core

Hormones & Behavior Core (Core C) Summary
The goals of the parent Program Project are to investigate possible mechanistic determinants of reduced
estradiol efficacy on female cognitive aging under pathological conditions, such as cardiovascular disease and
obesity. In order to assess mechanisms by which estradiol’s switch from beneficial for cognitive function to
neutral or even detrimental may occur, the projects in this proposal will investigate cognitive function in aging
female rodents under varying conditions of cardiometabolic health and disease both with and without estradiol
treatment. Core C (Hormones & Behavior Core) will facilitate this work and contribute to the success of the
overall Program Project through the completion of two specific aims. Aim 1 will establish a rodent model of
menopause and hormone therapy that is uniform across all four projects, and Aim 2 will enhance rigor and
reproducibility by standardizing the behavioral tests and assessments used across studies. Core services within
a program project are advantageous compared to independent investigations as they allow for careful planning
and coordination of research design, disease models, and data collection and analysis among all projects which
would otherwise prove difficult for researchers with separate grants at separate institutions. This coordination
will significantly impact the scope of the research by eliminating project-specific variability in biological age,
timelines, dietary components, and disease models and thus permitting inferences between studies that could
otherwise never be made.